Immune signatures of CMV disease risk after orthotopic liver transplant

ABSTRACT:
Background: Cytomegalovirus (CMV) is a highly seroprevalent human herpesvirus (HHV) of particular clinical
significance in the immunocompromised patient population. Solid organ transplant (SOT) from a CMV-infected
donor (D+) to a naïve recipient (D+/R-) leads to a unique mechanism of primary CMV infection in ~80% of
recipients. CMV disease, such as pneumonitis, retinitis, or primary CMV syndrome, occurs in ~30% of patients,
most commonly after cessation of antiviral prophylaxis after day 100. The immune mechanisms of protection
from disease risk in this scenario are not known, but this risk was reduced to 10% in a randomized, controlled
trial of pre-emptive therapy vs prophylaxis in orthotopic liver transplant (OLT) (CAPSIL study). Pre-emptive
therapy, where viremia is monitored and treated only when it reaches above pre-specified levels, is thought to
enable the development of immunity in the early post-transplant period. Evaluation of participant samples from
the CAPSIL study showed increased CMV-specific CD4 and CD8+ T cells, expression of markers of terminal
differentiation in the T cell and NK cell populations, and neutralizing antibody (nAb) levels in patients managed
with pre-emptive CMV therapy. A clinically useful measure of risk of CMV disease is urgently needed to guide
efforts at prevention. Summary of Proposal: We propose here to identify the factors of the humoral CMV
response most correlated with CMV disease risk and combine this with quantification of the CMV-specific T cell
repertoire by T cell receptor (TCR) sequencing and sequence-similarity methods. The Central Hypothesis is
that a measure of immunity inclusive of both humoral and cellular factors will be most informative to predict
disease risk. Rationale: While nAb levels, thought to substantially reflect antibodies specific to CMV surface
pentameric complex, are seen to be increased in patients treated pre-emptively for CMV, gB-binding antibody
levels are a known correlate of protection in primary, natural infection. Antibodies preventing cell-to-cell viral
spread may also be influential. Elucidation of the mechanism by which CMV nAb levels correlate with disease
risk in D+/R- OLT is needed. Prior to CAPSIL, T cell immunity was thought to be the primary mediator of CMV
protection in SOT but has not been shown to correlate with disease risk in D+/R- OLT. Intrinsic limitations of T
cell assay-based correlates of disease risk, such as lab-to-lab variability, would be improved by use of a
sequence-based measure. In Aim 1 we will characterize the neutralizing and non-neutralizing antibody
response and map the CMV-specific B cell repertoire in samples from the CAPSIL trial. In Aim 2, we will
quantify and characterize the CMV-specific T cell repertoire using TCR sequence-based analysis. We will
correlate findings from both Aims with the results from the CAPSIL trial to characterize the immune signatures
of CMV disease risk in D+/R- OLT. Together, these aims will inform further CMV disease prevention strategies,
the primary goal being identification of persons at high risk of CMV disease who would benefit from prolonged
monitoring, or persons at low risk of CMV disease who could safely shorten prophylaxis or monitoring.

Public health relevance
PROJECT NARRATIVE/ PUBLIC HEALTH RELEVANCE CMV, a highly prevalent herpesvirus, is transmitted in 80% of cases where naïve recipients receive an organ from an exposed donor (D+/R-) and 30% of patients develop potentially life-threatening CMV disease. This proposal will use samples from a recent randomized clinical trial of ‘watch and wait’ vs. antiviral prophylaxis to prevent cytomegalovirus (CMV) disease in solid organ transplant patients at highest risk of CMV disease: the ‘watch and wait’ approach is shown to allow for the development of an immune response to CMV in the early days after transplant. We propose here to identify the factors of the CMV immune response most correlated with CMV disease risk to inform future CMV disease prevention strategies.